T-LYMPHOCYTE ACTIVATION IN PBC AND PSC--EFFECTS OF CYCLOSPORIN ON T-LYMPHOCYTES

Study of the effects of cyclosporin on T-lymphocyte activities in primary biliary cirrhosis and primary sclerosing cholangitis.